ANALYSIS OF ESCRT FUNCTION IN ENDOLYSOSOMAL TRAFFICKING

Abstract
The endolysosomal network is the portal by which extracellular material enters the cell. As such, the
membranes of the endosomes, phagosomes, and lysosomes that comprise this network face challenges from
pathogens and other internalized materials as well as from metabolic and chemical stresses. Consequences of
damage vary according to the specific compartment and degree of damage, but extensive lysosomal
membrane permeabilization triggers cell death while limited disruption of endosomes and phagosomes by
particulate material and pathogens leads to inflammasome activation and ensuing cytokine responses. A
widely deployed strategy for removing damaged organelles involves the use of selective autophagy, referred to
as lysophagy. Removal is, however, unnecessary if organelles are instead repaired. We recently discovered a
new role for the ESCRT (endosomal sorting complex required for transport) machinery in responding to nano-
scale disruptions in endolysosomal membranes and promoting their repair.
In this project, we are building on this discovery and testing the hypothesis that ESCRTs (and in particular
ESCRT-III proteins) play a key role in maintaining endolysosomal integrity and function by recognizing and
repairing nanoscale membrane damage. This role for the ESCRT machinery is distinct from its widely
recognized function in intralumenal vesicle biogenesis and appears applicable at both the plasma membrane
and on internal organelles. Nanoscale damage involves short-lived nm-size pre-pore or pore(s) that reseal or,
above a critical threshold, expand to allow unrestrained content exchange. We are using a range of chemical,
physical, and biological stressors to define the signals as well as molecular and physical mechanisms
underlying ESCRT-mediated repair. The high-sensitivity and fast camera requested in this administrative
supplement application will replace a previous generation camera that has failed, allowing us to continue our
studies of the signals and molecules responsible for maintaining endolysosomal membrane integrity.

Public health relevance
The Endosomal Sorting Complex Required for Transport (ESCRT) machinery is known for its fundamental roles in remodeling cellular membranes to enable membrane protein degradation, HIV budding, and cell division. The work in this proposal builds on and extends our discovery that ESCRTs also stabilize and repair membranes throughout the endolysosomal network. Insight into how this machinery maintains compartmental membrane integrity has important implications for understanding inflammatory responses, pathogen invasion, and mechanisms underlying necrotic cell death.